Facility Maintenance

Through its four integrated service divisions, the Facility Maintenance and Operation Core (FAC-OPS) provides high containment operational management monitoring and oversight; routine facilities preventive maintenance and upkeep of the GNL physical plant that supports the entire facility including the high containment space and a preventative maintenance plan for all BSL4 equipment and systems; non-routine emergency repairs of BSL4 equipment and systems; and specialized training for facilities personnel working in and around BSL4 space and associated building systems. This core ensures continuous scientific support by combining management of base science support and high containment operational systems thus better maintaining synchrony with scientific program needs. Functional safety and security is ensured by independent oversight by autonomous entities from other cores that have supervisory responsibilities (biosafety, security, GMP& GLP compliance). The scientific, engineering and biosafety training activities within the GNL are interlinked with a succession of training experiences at increasing levels of biosafety for individuals with no previous experience within biocontainment. The progression of scientists and support staff through these levels is an important function of the training mission of the GNL which incorporates all levels of biosafety including BSL4. The amalgamation of science support, biocontainment and engineering services gives scientific and engineering staff increased opportunities to understand the integrated nature of such a facility and the importance of communication within the operational elements.

Public health relevance
The Facility Maintenance and Operation Core provides high containment management and oversight, preventive maintenance and upkeep of the GNL physical plant, and specialized training for facilities personnel working in and around the BSL4 labs and associated systems. Operations and maintenance is closely coordinated with scientific program needs to ensure optimum support and maximum productivity.